NHLBI ACQUISITION AND PROGRAM SUPPORT

Task Area #1: Acquisition Support – Support ITAC in the release and award of information technology and data science-related acquisitions by providing subject matter expertise and leading the development of acquisition materials in close collaboration with business owners, ITAC staff and the Office of Acquisitions (OA).

Task Area #2: Program Analysis Support – Support ITAC through review of acquisition performance, collecting feedback, analysis of contract use and trends, management and tracking, and projecting upcoming requirements.